Young Infants' Detection of Emotion

Project Summary
The perception of emotion starts with emotion detection, which reflects an ability to determine whether
emotional content is present. The detection of emotional information is evolutionarily relevant, in that it allows
for a rapid behavioral response when faced with threat. Emotion detection (and its relation to immediate threat)
has primarily been studied with adults and very little is known about the development of this critical ability. The
K99 portion of this proposal seeks to remedy the situation by testing infants for detection of emotional content
in very brief stimulus presentations (50ms, 100ms, 200ms, 400ms). The infants will be tested using happy,
angry, and fearful facial expressions and saccade latencies to different emotions will establish whether they
are differentially detected; specifically, if threat-related emotions (i.e., anger, fear) are detected faster than non-
threatening emotion (happiness). Additionally, eye-tracking and pupillometry measures will determine whether
infants are utilizing specific features to detect distinct emotions and whether pupil diameter, an index of
autonomic nervous system (ANS) function, is altered by emotional faces. Most importantly, the R00 phase of
this award will be used to study a longitudinal sample to assess individual differences in detection speed
across development and determine whether these relate to later developmental abilities. Candidate: The
candidate has her Ph.D. in Experimental Psychology and has 2 years of postdoctoral research experience.
She has a strong publication record despite a 4-year absence from her field due to health issues. With this
award, she will reach her potential to become a successful independent investigator. Training: Specific
training in the acquisition and analyses of eye-tracking data and the related measures of pupillometry will be
useful in her pursuit of a tenure-track position at a Research I/Doctorate Extensive university. Becoming
comfortable using MATLAB and conducting analyses using advanced statistical methods will be appropriate
training aims to facilitate this goal. KU’s Life Span Institute is an interdisciplinary research center focused on
development across the life span, and its collaborative environment will provide an ideal setting for the
proposed research. Research: Using a cross-sectional study with 3.5- and 7.5-month-old infants, the proposed
research will document the time course of emotion detection, potential preferential processing of threat-related
emotions, how low-level visual features influence detection, and how ANS activity is differentially modulated by
emotional content. The R00 phase will add an additional visit at 12.5 months and a follow-up assessment at 18
months. This study will establish cross-age stability across measures and examine their predictive validity for
developmental outcomes. Documenting the development of this vital skill in early infancy has potential
implications in the study of typical and atypical development, such as that in autism spectrum disorder.

Public health relevance
Project Narrative Quick detection of emotion has been widely studied with adults but little is known about how this perceptual ability develops. The proposed study will document the development of emotion detection; specifically, the time course of emotion detection, potential preferential processing of threat-related emotions, how low-level visual features influence detection, how autonomic nervous system activity is differentially modulated by emotional content, and whether speed of processing on emotion detection tasks influences later social development. This research has implications for typically and atypically developing populations, in that emotion detection is severely impaired in individuals with autism spectrum disorder and has cascading effects, such as deficits in online perception of fluctuating emotional states, perceiving social cues, efficient mimicry of emotional expressions, and basic empathy processes.